The Pathogenesis and Treatment of chronic GVHD

1) NIH BOS Montelukast trial (LAI): 22 patients enrolled to date. 19 patients have completed the primary endpoint. Interim analysis will be conducted this summer and analysis of immunological endpoints ongoing. 2) FHCRC new onset BOS trial (chair): open at NIH, one patient accrued at NIH. 3) Lung consortium trial: in development. 4) cGVHD myositis study of respiratory muscle: manuscript published. 5) AI ON CGVHD Natural history study. Manuscript on PFT function equations in submission.